Task X11:Evaluation of Clinical Samples from a Dengue Vaccine Clinical Trial

This contract provides for clinical and nonclinical sample testing for a dengue vaccine under the NIAID Preclinical Services for Evaluation and Testing Serves (ETS) Program.